Cortical Signature and Modulation of Pain

Cortical Signature and Modulation of Pain
Abstract/Project Summary
Pain perception contains two main dimensions: the sensory-discriminative and the affective-cognitive
aspects. In this proposal, we will focus on the cortical signature and modulations of the sensory aspects of
pain using mouse models. Pain can be largely divided into inflammatory or neuropathic pain. A common
condition in both types of pain is mechanical allodynia: externally applied innocuous gentle touch becomes
painful. Paradoxically, pain elicits self-initiated recuperative behaviors such as rubbing and massaging of the
painful regions; and the mechanical stimuli from such self-generated behaviors generally relieve pain. The
neural circuit mechanisms underlying the opposite effects of external versus self-applied mechanical stimuli
in pain conditions remain poorly understood. Based on previous research as well as our preliminary studies,
we hypothesize that corticospinal projecting neurons from primary somatosensory (S1) cortex facilitate
mechanical hypersensitivity in pain models, whereas specific motor cortex projection neurons play key roles
in suppressing tactile allodynia in self-initiated recuperative behaviors (such as licking and wiping in mice).
We further hypothesize that the cortical pain signature can be read out from activity patterns of large
populations of individual S1 neurons by comparing their activities in the painful versus non-painful or pain-
relieved conditions. We will use a combination of viral-genetic labeling of specific cortical neurons, in vivo
calcium imaging and in vivo multi-electrode extracellular recording in freely behaving mice, optogenetics-
assisted slice physiology, opto/chemicogenetic manipulations, and computational analyses to test our
hypotheses.

Public health relevance
Project Narrative How cortical circuits processes and modulate the sensation of pain remain poorly understood. The proposed research for this BRAIN application will uncover activity patterns of cortical neurons that are signatures of pain sensation through large scale imaging and recording studies, as well as delineating critical circuit elements linking motor to sensory cortex or connecting cortex to subcortical regions that either facilitate or attenuate pain. The results from this project are expected to aid the future development of effective neural modulatory strategies such as brain stimulations to relieve pain in chronic pain patients.